Efficacy and signaling modulation by targeting the sodium site at mu opioid receptor

ABSTRACT
Opioids until recently were the drugs of choice to treat moderate to severe chronic pain. Decades of intensive
research has led to the pharmacological characterization of countless synthetic and semi-synthetic opioid
derivatives. However, an ideal compound, devoid of serious side-effects such as respiratory depression,
dependence, and addiction, has not yet been identified. Opioid activation of mu opioid receptor (MOR) G protein
signaling pathways is believed to cause both desirable analgesia as well as undesirable adverse effects like
respiratory depression. Since MOR can couple with six Gi/o/z subtypes, namely Gi1, Gi2, Gi3, GOA, GOB and Gz, we
hypothesize that it may be possible to achieve functional selectivity by activating an individual Gα-isoform and/or
a combination of these isoforms. Our preliminary data shows that bitopics of fentanyl show unique Gi/o/z signaling
as well as a behavioral profile distinct from typical opioids. To this end, we have also obtained cryoEM structures
of MOR bound to one lead bitopics, C6 guano (3.3Å), and an analog of C6 guano named LG94 (3.4Å) getting
insights into distinct modes of ligand binding that also involves engagement of an allosteric binding site. We have
identified two distinct modes of engaging the sodium binding allosteric site in MOR and identified an antagonist
as well. In this study, we will interrogate Gα-subtype bias through screening of additional analogs, across both
fentanyl and morphinan based templates as well as novel indole-based templates and targeting the allosteric
site with additional bitopics with higher potency and optimal drug like properties. We will also develop a first in
class antagonist on the fentanyl template. High resolution cryoEM will be used on promising analogs to enable
structure-function studies and ligand binding fine-tuning. This, in turn, will enable us to design analogs that are
more effective and possibly display a more advantageous side-effect profile (no respiratory depression while
showing analgesia) than their parent compounds. These probes will also allow us to build a better framework for
understanding MOR Gα-subtype signaling and facilitate identification of useful preclinical candidates for the
treatment of pain/OUD in the near future. Furthermore, any novel antagonists could become tools in fighting
opioid-related substance abuse.

Public health relevance
Project Narrative Treatment of pain remains a major unmet need. Opiates continue to be useful pharmacotherapy for treatment of moderate to chronic pain but suffer from severe side effects, leads to initiation of opioid use disorders (OUD) and has led to an epidemic in America. The development of safe, effective and well tolerated pain medications without side-effects based on allosteric targets and/or distinct G-protein signaling within the mu opioid receptor will be a major advancement in the treatment of pain as well as OUD that would greatly enhance both quality and length of life of patients both in the US and worldwide.